The Role of Granular Acidification in the Pathogenesis of Type 1 Diabetes

PROJECT SUMMARY
Type 1 diabetes (T1D) is an autoimmune disease characterized by the destruction of insulin-producing beta
cells in the pancreas, leading to lifelong dependence on insulin therapy. Despite decades of research, the exact
triggers that initiate this autoimmune process remain elusive. This grant proposal aims to investigate a novel
mechanism that may explain the development and progression of T1D, focusing on the formation and role of
hybrid insulin peptides (HIPs) in beta cells. HIPs are unique autoantigens that form when pieces of insulin get
linked to other beta cell proteins. These hybrid molecules are not encoded in the genome and may be recognized
as foreign by the immune system, potentially triggering an autoimmune response against beta cells. Previous
research has shown that HIPs are present in a major mouse model of T1D and human patients, and that immune
cells reactive to HIPs can be found in the blood and pancreatic tissue of individuals with T1D. The researchers
propose that the formation of HIPs is influenced by various stressors that affect beta cells, such as changes in
blood glucose levels or exposure to inflammatory molecules. They hypothesize that these stressors alter the
internal environment of beta cells, particularly the acidity levels within insulin-containing granules, leading to
increased HIP production. This process may explain why some individuals develop T1D more rapidly than others
and why the disease can progress in a variable manner. To test these hypotheses, the research team will conduct
a series of experiments using human pancreatic islets and immune cells from T1D patients. They will investigate
how different stressors affect HIP formation and examine the relationship between cellular stress, HIP
production, and the recognition of beta cells by the immune system. Advanced techniques in mass spectrometry
and immunology will be employed to identify new HIPs and characterize their potential role in triggering
autoimmunity. Understanding the mechanisms of HIP formation and their role in T1D development could have
significant implications for the prediction, prevention, and treatment of the disease. If successful, this research
may lead to new strategies for identifying individuals at high risk of developing T1D before symptoms appear, as
well as novel approaches to protect beta cells from immune attack. Furthermore, insights gained from this study
could potentially inform the development of therapies aimed at preventing or slowing the progression of T1D,
ultimately improving the lives of millions affected by this chronic condition. By elucidating the complex interplay
between beta cell stress, HIP formation, and autoimmune activation, this research has the potential to
fundamentally change our understanding of T1D pathogenesis and open new avenues for intervention in this
challenging autoimmune disorder.

Public health relevance
PROJECT NARRATIVE This research project investigates how stress on insulin-producing beta cells leads to the formation of hybrid insulin peptides (HIPs), which may trigger the autoimmune response in type 1 diabetes (T1D). By studying how various stressors affect HIP production and how these HIPs interact with the immune system, we aim to uncover new insights into the development and progression of T1D. Our findings could lead to improved methods for predicting, preventing, and treating T1D, potentially transforming the management of this chronic autoimmune disease and improving the lives of millions affected by it.